Maternal regulation of microtubules in egg developmental competency

Project Summary
Vertebrate eggs lie dormant until fertilized, when a process called egg activation ensues that triggers the
completion of meiosis and other processes that initiate embryonic development. These processes occur within
the first several minutes after fertilization and depend on maternal factors supplied by the mother to the egg
during oogenesis. Maternal factors exclusively drive early embryonic development in all animals, since the
zygotic genome is not activated until at least one and typically several cell division cycles after fertilization. The
large maternal contribution to vertebrate embryonic development is evident by the large size of eggs and early
embryos compared to somatic cells (~10 to 1000 times greater, depending on the species). Moreover, unique
features of this stage of development, such as acentrosomal meiotic divisions and mitotic spindles that cannot
scale to the large cell sizes, necessitate unique maternal functions, not found in somatic cells. However, the
roles that maternal factors play and how their vast supply is regulated spatiotemporally in the large egg and early
embryo is little studied, despite its importance in reproductive success and fertility. The zebrafish provides an
excellent model for studying the maternal regulation of development in vertebrates. Many maternally-regulated
gene functions are conserved between zebrafish and mammals. Zebrafish eggs are externally fertilized, so are
easily accessible, and their large size and translucency is advantageous for live imaging with fluorescent
markers, which will be profited from here. A key event in egg activation is the completion of meiosis. At the end
of oogenesis in vertebrates, the mature oocyte and egg are arrested in metaphase of meiosis II. The second
meiotic division ensues when the egg is activated, thus generating the second polar body and a haploid
complement of chromosomes to contribute to the zygote. Meiotic divisions are unique in oocytes and eggs as
they lack the centrosome, the primary microtubule organizing center (MTOC) of a cell. While the meiotic
acentrosomal MTOC (aMTOC) proteome has recently been described, little is known about how acentrosomal
spindles are regulated and what normally restricts their nucleation in time and space. Here a zebrafish maternal-
effect mutant named volcán will be studied, which displays multiple ectopic spindle-like MTs in the single cell
blastodisc that cause a novel defect, the generation of numerous vesicle-like structures at the animal pole
potentially polar body-like structures, but devoid of DNA. The dynamics, etiology in development, and nature of
the spindle-like MT and vesicle-like structures abrogated by Volcan will be investigated, as well as the molecular
nature of the volcan gene. The results of these Aims are expected to reveal the molecular identity of a key protein
acting to restrict formation or organization of aMTOC spindle MTs in the egg to ensure a single polar body-like
structure is extruded and that the egg is competent for embryonic development. These studies have direct
relevance to reproductive success and women's fertility, including potential targets for infertility treatments.

Public health relevance
Project Narrative: Factors provided to the egg by the mother drive development of the fertilized egg and early embryo, however, little is known about this maternal regulation in vertebrates. This study will identify a new factor that acts in regulating the cytoskeleton, giving competency to the vertebrate egg to proceed in embryonic development and has direct relevance to human reproductive success and female fertility.